Regulation of NKCC2 isoforms and blood pressure by tumor necrosis factor-alpha

We previously showed that tumor necrosis factor-alpha (TNF) produced within the kidney is part of a system
that regulates renal function and the blood pressure (BP) response to increases in dietary salt intake via
inhibition of the Na+-K+-2Cl- (NKCC2) cotransporter. Thus, we developed two mouse models in which TNF has
been genetically deleted in the: 1) thick ascending limb of Henle’s loop (TAL), and 2) distal nephron
downstream of the proximal tubule (PT), which will be applied to determine the role and mechanisms of TNF
produced by renal epithelial cells as part of an emerging intratubular TNF system that attenuates increases in
BP induced by high salt (HS) intake. A complementary approach, using PT- and TAL-specific TNF silencing
lentivirus constructs, will be used to specifically inhibit TNF production by these nephron segments to define
the contribution of TNF derived from renal epithelial cells to the regulatory effects of this cytokine in the kidney.
The genetic and lentivirus approaches also will be used to determine the molecular mechanisms by which TNF
regulates NKCC2 phosphorylation and isoform expression, renal function, and BP. Preliminary data indicate
that TNF, via activation of TNF receptor 1 (TNFR1), inhibits phospho-NKCC2 (pNKCC2) expression by a
mechanism involving activation of the serine/threonine phosphatase, calcineurin (CN). The effects of TNF on
CN in the kidney have not been studied, thus experiments will address TNF-dependent increases in CN activity
as well as expression of the catalytic subunit CNAb and regulatory subunit CNB. The genetic and lentivirus
strategies will be adapted to determine the effects of salt intake on TNFR1-dependent CN-mediated inhibition
of pNKCC2 expression, electrolyte excretion, and the BP response to HS intake. Fine-tuning of NKCC2
function is dependent upon the NKCC2A and NKCC2B isoforms, which are strategically localized along the
mammalian TAL and contribute to regulatory functions in response to high and low salt conditions,
respectively. TNF inhibits the expression of these isoforms suggesting a role for this cytokine in both the mTAL
and cTAL/MD segments of the TAL. Moreover, TNF regulates renal function involving these isoforms in a
manner that limits reabsorption of NaCl. However, the molecular mechanism by which TNF suppresses
NKCC2A and NKCC2B mRNA accumulation in response to high and low salt intake, respectively, has not
been determined. miRNA profiling of the TAL in combination with preliminary data have identified miRNAs that
regulate NKCC2 isoform mRNA abundance, phosphorylation and BP, the first data to show NKCC2 function is
regulated by a miRNA-dependent mechanism. TAL-specific lentivirus manipulations will link miRNA-195
expression induced by TNF derived from the TAL to a NKCC2A-dependent mechanism that attenuates BP in
mice ingesting HS. Collectively, the studies will reveal mechanisms by which an intratubular regulatory system,
in which TNF produced by renal tubular epithelial cells in response to increases in salt intake, regulates
NKCC2 isoform expression, phosphorylation via CN, electrolyte excretion, and contributes to BP homeostasis.

Public health relevance
Hypertension is an important risk factor for the development of heart disease, stroke, and kidney disease that affects greater than 40% of the population in the United States. Many hypertensive patients, especially African Americans, exhibit sensitivity to salt. Exaggerated stimulation of ion transporters in the kidney of these individuals increases the retention of salt, which heightens elevations in blood pressure associated with an increase in dietary salt intake. Our study will determine the mechanisms that regulate an intratubular TNF system that is activated in renal epithelial cells in response to increases in dietary salt intake and attenuates salt-dependent increases in blood pressure.